Cell Imaging and Histology

ABSTRACT – CELL IMAGING AND HISTOLOGY SHARED RESOURCE
The mission of the Cell Imaging and Histology Shared Resource, which is managed by the Cancer Center, is to
provide state-of-the-art imaging and histological services to Center researchers. The Core offers the
instrumentation, expertise, training, and service to enable advanced cellular imaging and data analysis. The Cell
Imaging facility's technology includes a recently acquired hybrid confocal/super-resolution Nikon A1 microscope
system equipped for live-cell imaging, as well as three other confocal microscope systems—a Zeiss LSM 710
NLO laser point scanning system equipped with a multiphoton laser, An Olympus FloView 1000, and a Yokogawa
spinning disk confocal microscope. In addition, the facility has six other fluorescence microscopes supporting a
wide range of imaging technologies such as FRET, TIRF, live cell and time-lapse imaging. Most of the advanced
microscopes at SBP are located within the facility. The facility's computer workstations provide access to image
analysis software packages including Image-Pro plus, MetaMorph, Volocity, and Imaris 8.0, as well as Nikon
software for off-line reconstruction of Nikon Super-Resolution data. The Histology facility services include
preparation and cryosectioning of tissues; automated staining for H&E (Leica XLf), and immunohistochemistry,
immunofluorescence, and in situ hybridization (Leica Bond RX). The facility's Aperio slide scanners (AT2 and FL
ScanScopes, Leica) provide automated high-resolution scanning of whole IHC or fluorescence stained slides for
data documentation, analysis, storage, and dissemination. The facility also provides assistance in obtaining
human tissues, including assistance with IRB and MTA issues. Both the adjacent Cell Imaging and Histology
facilities provide user training or full-service. Trained microscope users have 24/7 access to the equipment, with
reservations for each instrument made through an on-line iLab calendar. The Core is very broadly used—in the
past 5 years, the Core has contributed to research in 47 Cancer Center member laboratories representing all
three Center programs and assisted in projects resulting in more than 190 cancer-relevant publications.